The UC Davis enhanced Molecular, Cellular, and Developmental Biology Training Program

ABSTRACT
The primary goal of the enhanced Molecular, Cellular, and Developmental Biology (eMCDB) Training Program
at UC Davis is to ensure the success of our diverse predoctoral Trainees in graduate school and prepare them
for impactful careers in the biomedical workforce by nurturing productive, rigorous, resilient scientists and
confident communicators. A secondary goal of the eMCDB Program is to enhance the training and career
development of a broad cohort of PhD students at UC Davis by extending our activities far beyond our
Program.
A dynamic and experienced team of 63 Faculty Trainers from 18 academic departments will provide our
training. These trainers, carefully selected from the top molecular, cellular, and developmental biologists on
campus, offer wide-ranging interdisciplinary training in basic and translational life science research. Each has
an active research program, a successful track record of mentoring, and a commitment to fostering safe,
inclusive, and supportive training environments. Trainees are selected from the most qualified graduate
students across five affiliated Graduate Groups through a holistic process that recognizes and values their own
cultural individualities. Training is accomplished by integrating Graduate Group coursework and mentored PhD
dissertation research in individual laboratories with a coherent set of curricular and training activities developed
by this Program to support each Trainee’s growth along six skillsets critical for graduate training and lifelong
career progression: scientific rigor, communication, wellness and resilience, mentoring, career development,
and diversity. The effectiveness of our Program’s activities will be regularly and rigorously evaluated to allow
Program leadership to adapt and ensure that Program goals are met. Our activities, whenever possible, will be
offered to all graduate students in biological sciences at UC Davis, consistent with our goal to enhance training
and career development broadly, and in an effort to build community.
We are confident that this Training Program will thoroughly prepare our Trainees for the changing technical
and intellectual climate faced by the next generation of basic biomedical scientists. This Training Program
requests support for 16 predoctoral student slots to support eight Trainees for two years each, during the
second and third year of their PhD training. Institutionally, UC Davis has made major commitments to establish
a vibrant faculty and cutting-edge infrastructure to support research in molecular, cellular, and developmental
biology. The substantial institutional support allocated to this Training Program further reflects our shared goals
to deliver outstanding, high-quality graduate training for eMCDB Trainees and our commitment to support the
development of the national biomedical research workforce.

Public health relevance
NARRATIVE The UC Davis enhanced Molecular, Cellular, and Developmental Biology (eMCDB) Training Program will provide high quality predoctoral training to its diverse Trainees and prepare them for impactful careers in the biomedical workforce. This will be accomplished by a coherent set of enhanced training activities aimed at nurturing productive, rigorous, resilient scientists and confident communicators.